PTPRD phosphatase inhibitors for stimulant use disorders

Specific Aims: Illicit and prescribed stimulants provide major challenges in the US. In a recent year, almost
7.5 million Americans reported cocaine or methamphetamine use. More than 32 million amphetamine
prescriptions were written for disorders including attention deficit hyperactivity disorder and narcolepsy. 1.75
million Americans reported cocaine or amphetamine or use disorders. There were more than 212,000
admissions to stimulant use disorder treatment programs. A “fourth wave” of US drug overdose deaths
includes many individuals who use stimulants. However, individuals who seek to quit stimulant use have no
pharmacological treatment approved by FDA. Medication development portfolios aimed at treating stimulant
use disorders should include new drugs acting at novel targets that are as well-supported as possible, a priori,
by human and other data.
Robust human, mouse model and pharmacologic data now support PTPRD (receptor type protein tyrosine
phosphatase D) as a novel target for treatment of stimulant use disorders and, perhaps, their prevention.
Human PTPRD genomic variants are associated with: a) vulnerability to develop a stimulant use disorder, b)
the extent of reward from stimulant administration and c) levels of brain PTPRD expression. Mice that express
less PTPRD display less reward from stimulants. We have characterized an initial PTPRD phosphatase
inhibitor, 7-BIA, and a more potent/selective congener, NHB1109.
NHB1109 features support its development as a medication. We can now synthesize NHB1109 readily from
commercially-available precursors. NHB1109 is selective. It displays greater potency at PTPRD than at most
other tyrosine phosphatases. It has no significant activity in EUROFINS screens of targets of current drugs.
NHB1109 is bioavailable in rats after oral dosing. It is relatively stable. It has intellectual property protection. It
substantially reduces cocaine conditioned place preference in wildtype mice, but not in PTPRD knockouts.
Acute or repeated NHB1109 doses up to 300 mg/kg provide no toxicity. Mice survive 2,000 mg/kg gavage
doses, but develop a dose-limiting toxicity, ileus.
This exciting identification of NHB1109 as a novel, potent, selective small molecule PTPRD phosphatase
inhibitor with proof of in vivo pharmacological activity in reducing stimulant reward and a reasonable
therapeutic index leads us to seek Avant Garde support. We will move NHB1109 forward through IND-enabling
work, initial use in humans and completion of phase I human studies. We will continue studies of backup
compounds should NHB 1109 display unanticipated limitations. We will complete antecedents to FDA IND
approval including metabolic, two-species toxicity and carcinogenicity screens. We will receive IND approval
and complete first in human, ascending dose and repeated dose research volunteer studies, including those
with amphetamine challenge doses. We will advance development of NHB1109 to address unmet needs in
treating devastating stimulant use disorders via these UG3 and UH3 Aims:
UG3 Aim 1: To develop pharmacologic and toxicologic evidence in vitro and in two species that robustly
support an IND application for use of NHB1109 (or backup compounds if required) in normal human research
volunteers.
UG3 Aim 2: To develop pharmacologic and toxicologic evidence in two species that robustly support an IND
application for use of challenge doses of stimulants along with NHB1109 in normal human research volunteers.
Milestones for the end of the UG3 support period: Filing a successful FDA IND application for NHB1109 human
use without, then with, amphetamine challenge doses.
UH3 Aim 1: To complete good manufacturing practices syntheses, formulations for human use, ascending
dose and repeated dose studies with monitoring of toxicities and pharmacokinetic/pharmacodynamic
properties in normal human research volunteers.
UH3 Aim 2: To complete repeated dose studies with challenge doses of amphetamine in normal human
research volunteers with monitoring of toxicities and pharmacokinetic/pharmacodynamic properties in normal
human research volunteers. To complete antecedents to longer use in humans.
Milestones for the end of the UH3 period of support: Robust data on NHB1109 tolerability, toxicities and
pharmacokinetics/pharmacodynamics in humans, some of whom also receive challenge doses of
amphetamine. Initial pilot data for stimulant reward in NHB1109- vs placebo-treated research volunteers.
These data will set the stage for subsequent and more definitive phase II work to test NHB1109 effects on
reward from amphetamine and ability to maintain abstinence in treatment-seeking individuals with stimulant
use disorders. The data will enable subsequent use in prevention studies. They will provide strong bases for
further development of NHB1109 with continuing NIDA and pharma partnerships.

Public health relevance
Narrative/relevance: Human and mouse studies now identify roles for PTPRD variation in drug reward, addiction and ability to quit, while PTPRD phosphatase inhibitors reduce reward from stimulants. We have synthesized and tested 70 novel PTPRD ligands, identifying NHB1109's potency, selectivity, oral bioavailability and efficacy in reducing stimulant reward in rodents. We will advance NHB1109 to and through phase I testing in humans, allowing subsequent human tests that will validate NHB1109 as a novel agent for treatment of stimulant use disorders and, perhaps, their prevention.